Exercise Response in Humans with Obesity

Our preliminary data implicates inflamed adipose tissue as a factor that may lead to biochemical abnormalities
in muscle and attenuate some of the adaptive responses to exercise in obese individuals. The objective of this
project is to evaluate a hypothesis that adipose tissue inflammation activates inflammatory cascades in skeletal
muscle that, in turn, attenuate molecular responses to exercise.
Aim 1 will determine how adipose tissue phenotype influences skeletal muscle function and exercise
response parameters in humans. Humans with obesity will complete studies to assess molecular response
to acute exercise from protein synthesis rates, mRNA of exercise-responsive genes, and activation of signaling
proteins in skeletal muscle. Subcutaneous adipose tissue (SAT) and intermuscular adipose tissue (IMAT) will
be assessed using a combination of non-invasive imaging and biopsy-based molecular phenotyping. This aim
will determine if acute exercise response is attenuated with increasing IMAT or in people with inflamed adipose
tissue phenotype.
Aim 2 will determine the mechanisms by which SAT and IMAT secretomes influence muscle phenotype
and exercise response. Primary muscle cultures and adipose explants (SAT and IMAT) will be generated
from participants in Aim 1. Myotubes will be exposed to conditioned media from IMAT, inflamed SAT, or non-
inflamed SAT to evaluate their influence on molecular phenotype and exercise response pathways. Genetic
and pharmacological approaches will be used to target key inflammatory pathways in skeletal muscle (TLR4,
IKK, JAK/STAT) to assess their roles in exercise response in vitro.
The contribution of the proposed research is expected to be a detailed understanding of the mechanistic links
between adipose tissue inflammation, local inflammatory responses in skeletal muscle, and molecular
response to acute exercise. The knowledge gained in the proposed study will have a positive impact because
“exercise resistance” represents a significant barrier to the prevention and reversal of disease and disability in
humans, and understanding the role of anatomically distinct adipose tissue pools in skeletal muscle physiology
may lead to new approaches to enhance the beneficial adaptations to exercise in populations that stand to
benefit most. Discovering new ways to enhance training responses in people, particularly those at risk for
metabolic disorders, will have significant benefit since exercise non-responders have increased risk for
metabolic disease.

Public health relevance
The proposed research is relevant to public health because it will have a positive impact on developing new approaches to lessen the burden of obesity. Specifically, this project will provide new fundamental knowledge of how inflammation, particularly adipose tissue inflammation, influences skeletal muscle molecular responses to exercise. The project is relevant to the mission of NIDDK because it satisfies a critical need for understanding factors that contribute to variability in exercise response, particularly in individuals with obesity.